Determinants of Intracranial Aneurysm Growth

Abstract: Intracranial aneurysms present a formidable risk of death or devastating injury either from mass effect or hemorrhage. Aneurysms are detected with a broad range of sizes on first presentation. However, little is known about the rate of progression of aneurysms over time. It has long been suspected that hemodynamic forces play an important role in the genesis and rupture of aneurysms, but there is, to our knowledge, no literature that demonstrates which hemodynamic descriptors of an aneurysm are predictive of future growth. Recent results from the International Study of Unruptured Intracranial Aneurysms demonstrate that the risk of attempting a repair of aneurysms smaller than 7 mm in diameter exceeds the benefit from that intervention. There is now, therefore, a group of patients with saccular intracranial aneurysms who are not being treated, and who can be followed by non-invasive imaging. These patients are part of a broader group of patients with aneurysms of the intracranial circulation for whom there are no safe and effective interventions. The goal of this project is to monitor such patients on a bi-annual basis with non-invasive Magnetic Resonance Imaging. Using boundary values (geometric and velocity) obtained from patient-specific in-vivo imaging, Computational Fluid Dynamics (CFD) simulations will be performed to determine the hemodynamic conditions in each aneurysm. Progression over time in aneurysm lumen volume and/or volume of intralumenal thrombus will be measured from co-registered serial imaging studies. A relationship between different candidate hemodynamic variables and observed aneurysm growth will be sought. Specifically, we hypothesize that, specifying a low wall shear stress threshold value, the larger the surface area is with wall shear stress below that threshold value the greater will be the increase in aneurysm volume over time. In addition to using the standard methodology already established, we will develop new imaging capabilities, and will implement more comprehensive measurements of flow velocities throughout the vascular territory of interest. Our CFD methods will be extended to model non-Newtonian effects, and the in-vivo velocity measurements will be used to select which model is most suitable. As these new tools become available they will be used to improve the accuracy of our methods. This project represents an effort in translational research directed at an important component of neurovascular disorders.

Public health relevance
Project Narrative: This project proposes to examine the influence that forces exerted by flowing blood have on the progression of aneurysms in the brain. The project will use non-invasive MR imaging to monitor changes in aneurysm anatomy over time and numerical simulations to calculate the hemodynamic forces. The project will provide insight into the underlying mechanisms of aneurysm progression and could help in guiding treatment for this devastating condition.